Extending ezBIDS, NiiVue and dcm2niix for user-friendly cloud-based integration and visualization

Project Summary/Abstract
Cloud-based analyses and easily shared data formats are revolutionizing neuroimaging. We will develop
software to fill gaps created by these two trends. We will develop and refine software to visualize and analyze
the data from the BRAIN Initiative. Our team’s visualization tools and dcm2niix conversion tools are core tools
for our community. Our latest generation NiiVue brings our tools to the cloud. NiiVue uses innovative
visualization techniques to display the voxel, mesh, streamline and connectome formats common in our field.
NiiVue is able to work on any device – computer, phone or tablet and is able to exploit modern high-resolution
displays, advanced graphics card capabilities as well as touch and mouse input. We will develop wrappers for
our modular NiiVue software to address gaps in our field. First, we will extend our existing ezBIDS which eases
the creation of shared data to improve intention prediction, make defacing more robust, provide visual
confirmation for automated steps and ease transfer of anonymized data to public repositories. Second, our
afNiiVue desktop tool will provide a modern interface for interacting with the AFNI numerical tools. Third, our
cloud-based niiCloud web pages will aid scientists in configuring image processing and analyses as well as
inspecting the results. Finally, the jupyter notebook based ipyNiiVue will provide state of the art visualization for
scientists using Python.

Public health relevance
Project Narrative Two disruptive changes are revolutionizing the field of neuroimaging: cloud-based analyses and easily shared data formats. We will develop tools to fill gaps created by these paradigm shifts. We will make it easier to create curated shared datasets to improve automated image intention prediction and face removal with visual confirmation for the accuracy of these steps. We will develop desktop, cloud, and embedded Jupyter notebook visualization tools. Our cloud visualization tools will allow users to view analyses on any device (computer, tablet, phone).